Mechanisms of eosinophil-associated heart disease

PROJECT SUMMARY Cardiac complications occur in 20-60% of patients with peripheral blood hypereosinophilia irrespective of the cause—hypereosinophilic syndrome (HES), eosinophilic granulomatosis with polyangiitis (EGPA, formerly known as Churg-Strauss syndrome), drug reaction, or parasitic infection. Importantly, heart disease is the main cause of morbidity and mortality in this diverse group of patients. There is a paucity of models that adequately replicate cardiac disease in hypereosinophilia, which hinders mechanistic research that would identify therapeutic targets and advance clinical practice. To address this gap, we recently developed a mouse model of eosinophilic myocarditis that recapitulates many of the features of the disease including eosinophilia with heart involvement leading to early death. Our long-term goal is to understand the cellular and molecular mechanisms of eosinophil-mediated tissue damage. The objective of this grant is to use this mouse model to address critical questions regarding the pathophysiology of eosinophil-mediated cardiac disease. Our central hypothesis is that eosinophils and specific types of eosinophil cell death have a pathogenic role in eosinophilic myocarditis. We propose two specific aims: 1) define the role of eosinophils and their regulated necrosis in eosinophilic myocarditis; and 2) test for evidence of regulated necrosis and anti-eosinophil autoantibodies in patients with eosinophil-associated diseases. These contributions are significant because heart disease is the major cause of morbidity and mortality in patients with hypereosinophilic diseases; the studies in this grant application will enable directly testing mechanistic hypotheses in a model of eosinophilic myocarditis with features reminiscent of those seen in patients with heart disease as a consequence of hypereosinophilia. This project is innovative because it proposes to test innovative hypotheses, including the role of a recently described mode of biochemically regulated and thus targetable eosinophil cell death. Furthermore, the approach is innovative in that we use a new mouse model of spontaneous eosinophilic myocarditis. Understanding more about cardiac disease in a hypereosinophilic setting will provide mechanistic insights that may be generalizable to other conditions of eosinophil-associated heart disease.

Public health relevance
PROJECT NARRATIVE Despite intense research and recent advances in clinical care, eosinophilic disorders are not well controlled in a substantial subset of patients, resulting in significant morbidity and even mortality. Specifically, heart disease is the main cause of morbidity and mortality in this group of patients; yet, models that adequately recapitulate the main findings of heart disease in patients with hypereosinophilia are lacking. We propose to use our recently developed model of hypereosinophilia with heart disease to test mechanistic hypotheses that are expected to yield therapeutic targets.